RAPs-mediated post-transcriptional control in Apicomplexan parasites

Project Summary/Abstract
In the malaria parasite, gene regulation is heavily dependent on mechanisms acting at
the post- transcriptional and translational levels. More importantly, Plasmodium possesses many
atypical characteristics in both pathways when compared to its human host. These unusual
features hence extend our therapeutic window against this deadly parasite, yet these
characteristics have been poorly explored at the molecular level. The main goal of this project is
to characterize the role of newly identified apicomplexan-specific RNA- binding proteins {RAPs) in
parasite development and virulence, and to validate their potential as novel drug targets.
The fact that Plasmodium parasites modulate part of his gene expression at the post-transcriptional
level was inspired by many early studies that demonstrated that the global proteomic profiles often
lagged behind the transcriptional profiles. Our newly published large-scale bioinformatics
reinforce this conjecture as we determined that at least 18% of all coding-gene are predicted
to be potential RNA binding domain-containing protein (RBP). Furthermore, many of these parasite
RBPs were experimentally shown to interact in situ with mRNAs. In all eukaryotic organisms,
RBPs are essential to regulate mRNA processing at multiple levels including splicing,
transport, mRNA stability and turnover, as well as mRNA localization and translational
efficiency. In the human malaria parasite, very few RBPs have been characterized. We propose to
address this knowledge gap by examining the function of the parasite specific RNA-binding
domain proteins abundant in Apicomplexans, or RAPs. More specifically, we will use
state-of-the-art genomics, molecular, and cellular approaches to determine the role of the 21
identified RAPs in parasite development and survival. In Aim 1, we will characterize the
essentiality, subcellular localization and phenotypes of RAPs in P. falciparum across
different developmental stage using novel CRISPR/Cas9 approaches. In Aim 2, we will define the
global RAP- related ribonucleoprotein interaction network across various parasite
developmental stages by developing high-throughput sequencing technologies and pull-down
strategies followed by mass spectrometry analysis. Our complementary approaches will not only
identify key specific RBPs contributing to parasite development, but also uncover unique
post-transcriptional networks in a eukaryotic human pathogen. By providing
fundamental insights into mechanisms regulating translation in Plasmodium, this project will
improve our ability to design new drugs and novel lines of defense against malaria and many other
infectious disease agents.

Public health relevance
Apicomplexan parasites, such as Plasmodium, possess many atypical characteristics compared to their human host in both of the post-transcriptional and translational pathways regulating gene and protein expression. This project is designed to characterize at the molecular level, apicomplexan-specific mRNA-binding proteins (RAPs) that are essential to the parasite development throughout its infectious cycle and validate them as new drug targets.